EFFECT OF BETA-2 AGONIST ON MUSCLE MASS IN PROGRESSIVE MUSCLE WASTING DISORDER

The primary aim of this muscle mass (as determined by a 24 hour urine creatinine excretion), in patients with FSHD. A secondary aim is to determine if albuterol increases strength or timed functional tests in these patients.